Improving patient and clinician safety during COVID-19 through a rapidly adaptive simulation intervention

Project Summary-Abstract
The extended response to the novel coronavirus 2019 (COVID-19) pandemic has increased clinician work
burden and risk for infection while creating an environment of uncertainty, especially as easing of government
lockdown measures and potential additional surges of infection are expected in the near future. System
responsiveness and clinician preparedness are needed to prevent safety threats for both patients and staff.
Rapidly evolving care guidelines for COVID-19 patients result in continuous changes to implementation at the
bedside, presenting the opportunity for unintended consequences and the introduction of latent safety threats.
Clinician exposure to acute occupational stress events can lead to an activation of the sympathetic nervous
system, resulting in key physiologic changes including a decrease in heart rate variability. Repeated or
continuous stress exposure, leading to lower heart rate variability, is linked to increased medical errors and
decreased patient satisfaction. Simulation, a technical field that applies experiential techniques to practice,
learn, evaluate, test, systems or human actions, provides a proven methodology for improving system
responsiveness and process improvement.
We recently developed and piloted a new rapidly adaptive simulation intervention to increase guideline
adoption and preparedness for COVID-19 care delivery. Building upon this work, our overall goal is to develop
and test the COVID-19 Responsive Intervention: Systems Improvement Simulations (CRI:SIS), a simulation-
based training and quality improvement intervention that will minimize physician stress and improve system
responsiveness. To accomplish this goal, we will first identify facilitators, barriers, and unintended safety risks
in the adoption of new COVID-19 guidelines through in-depth interviews with emergency physicians and
structured field observations during the care of critically ill COVID-19 patients. Next, we will conduct a two-site
randomized clinical trial to test the efficacy of CRI:SIS as a simulation-based preparedness intervention on
decreasing emergency physician stress and anxiety during the care of COVID-19 patients in the ED through
on-shift measurements of heart rate variability as a physiologic marker of stress and responses to the State-
Trait Anxiety Inventory post-shift. Finally, we will test CRI:SIS as a process improvement strategy through rapid
cycle iterative loops of simulation-based testing of guidelines and design prototyping with our departmental
administrators, measuring changes to the AHRQ Hospital Survey on Patient Safety Culture. We will rapidly
disseminate CRI:SIS as two simulation interventions, one on clinician preparedness and the other on system
improvement, through interactive virtual tele-simulations, webinars, and virtual workshops providing mentorship
and shared learning for other institutions facing similar challenges. If proven successful, our simulation-based
CRI:SIS intervention to rapidly prepare clinicians and improve system responsiveness can be widely
disseminated to other institutions to combat the anticipated lengthy response to COVID-19 safety challenges.

Public health relevance
Project Narrative During COVID-19, increasingly prevalent occupational stresses are threatening safe, high-quality patient care and system responsiveness. We will identify safety barriers to adopting COVID-19 guidelines in the emergency department, assess the impact of a simulation-based preparedness intervention on physician stress and anxiety, and test a simulation-based process improvement strategy to increase emergency department safety culture during COVID-19. We will disseminate these programs through virtual demonstration and mentoring for institutions across the nation, establishing programs to actively engage front line clinical care workers in safety improvement efforts to ensure both patient and clinician safety in their local care areas.